The Impact of Sensitivity to Fast Spectrotemporal Chirps on Speech Encoding in the Mammalian Inferior Colliculus

Sensitivities of the mammalian auditory midbrain to complex sound features can provide the basis for encoding
schemes of critical stimuli such as speech. Recent work in rabbit inferior colliculus (IC) has revealed a novel
feature sensitivity to fast spectrotemporal chirps. Individual IC neurons had dramatic differences in response
rate to differing chirp directions and velocities. The stimulus used in that work was the Schroeder-phase
harmonic complex (SCHR), which contains a chirp within each pitch period because of the phase properties of
harmonic components. Speech necessarily contains similar chirps due to phase differences between harmonic
components resulting from vocal tract filtering. Given that IC neurons may be as sensitive to chirps in vowels
as they are to SCHR chirps, we hypothesize that novel chirp sensitivity in the IC significantly contributes
to speech coding at the level of the auditory midbrain. The goal of this proposal is to more precisely define
this sensitivity in the mammalian central auditory system to fast chirps using physiological experiments, design
an IC computational model that accurately reflects chirp sensitivity, and to assess whether chirp sensitivity
plays a role in speech coding. We will design novel sound stimuli to interrogate IC chirp sensitivity more
directly, and to disentangle chirp sensitivity from other known IC properties, such as periodicity tuning.
Computational models will be proposed using a base assumption that chirp-sensitive IC neurons receive two or
more inputs of differing frequencies and respond differently depending on input arrival times. We will analyze
chirp cues contained in speech using novel analysis methods. Finally, we will evaluate the importance of chirp
sensitivity for speech coding by comparing the ability of a chirp-sensitive and -insensitive models to predict
physiological speech responses. This work, when completed, will result in a new understanding of how the
subcortical auditory system encodes speech and complex sounds. This work will also represent one of the first
attempts to characterize and define this novel midbrain phenomenon. The findings of this proposal will help
identify new stimulus features that may be used as cues for next-generation hearing aids to assist speech
comprehension in noisy environments. The proposed training plan will concentrate on improving skills such as
computational neuroscience, advanced signal processing, data analysis, statistical hypothesis testing and
experimental design, all skills necessary for the completion of the proposed research. Training will also
address communication skills, such as verbal and written presentations, which will be demonstrated by
participation in conferences and generation of journal publications. The University of Rochester represents an
ideal location to complete the proposed research, providing an environment with easy access to experts in
auditory neuroscience and related fields, as well as many opportunities to participate in career-building
activities, workshops, and seminars to help reach professional goals.

Public health relevance
Narrative Sensorineural hearing loss (SNHL) affects an increasing number of people as our population skews older and exposure to dangerous noise levels becomes more commonplace. Understanding speech in background noise continues to be a major obstacle facing people with SNHL that is not resolved by existing medical devices. This research has public health implications because its findings may represent an additional cue used for speech coding that may factor into the development of next-generation hearing aids.